Core C - Functional Genomics and Computational Biology Core

CORE SUMMARY
The overall goal of this PPG application is to compare and contrast the mechanisms by which the inhibitory
receptors PD1 and LAG3 operate on T cells in the context of tolerance and autoimmunity, cancer, and chronic
infection. One major approach to be used throughout the studies is the application of genome-wide
transcriptional profiling. The purpose of the Functional Genomics and Computational Biology Core (Core C) is
to provide essential and centralized sequencing-based genomics services for all three Projects in this Program.
In addition, this Core will operate provide the service of a retroviral (RV)-enforced expression and knockdown
platform that can directly test in vivo individual genes and pathways identified from computational analyses. Thus,
Core C will provide integrated bioinformatic and computational analytical platforms and data integration services
coupled to downstream RV-enforced expression and knockdown as well as in vivo CRISPR/Cas9-focused
genetic screening. The Aims are:
AIM 1: To provide initial data hosting, normalization, preprocessing, and analysis as well as perform
cross-Project data integration and computational network modeling for bulk and single-cell
transcriptomic and epigenetic datasets. Core C will (i) provide raw data QC, data cleaning, pre-processing,
and generation of files for downstream analyses as well as operate a web portal interface for user exploration of
the data; (ii) perform primary and secondary genomics data analyses; and (iii) perform network and integrated
analyses including. The Core also will support and/or develop new analytical tools as technologies become
available (as for scRNA-seq in the last cycle).
AIM 2: To enable in vivo CRISPR/Cas9 screening and provide an RV-enforced expression and
knowckdown platform for downstream in vivo interrogation of genes and pathways regulated by PD-1
and/or LAG3. Core C will aid in design of CRISPR screening libraries for in vivo CRISPR screening platforms
by the Projects as well as downstream data analysis. Core C will also provide an in vivo retroviral platform to
enforce expression or shRNA knock-down of high-priority GOIs.
By its nature, Core C is highly interactive with other components of this PPG. Samples from Projects 1, 2, and
3 will enter Core C, which will analyze samples with input from the Projects and integrate results among the
three Projects. Core C will interact heavily with Cores A, B, and D for administrative support and to identify gene
targets for novel mouse strains and immunostaining analysis.

Public health relevance
CORE NARRATIVE Chronic infections with viruses such as HIV, HCV and HBV affect half a billion people and are significant causes of morbidity and mortality. T cell dysfunction or “exhaustion” is a major immunological defect during these infections and can be modeled with LCMV infection in mice. The studies proposed will define the role of the inhibitory receptors PD-1 and LAG-3 in CD8+ and CD4+ T cell exhaustion and provide new insights into how to reverse and avoid T cell exhaustion and improve immunity during these and other chronic infections.